Informatic tools for predicting an ordinal response for high-dimensional data

DESCRIPTION (provided by applicant): Health status and outcomes are frequently measured on an ordinal scale. Examples include scoring methods for liver biopsy specimens from patients with chronic hepatitis, including the Knodell hepatic activity index, the Ishak score, and the METAVIR score. In addition, tumor-node-metasis stage for cancer patients is an ordinal scaled measure. Moreover, the more recently advocated method for evaluating response to treatment in target tumor lesions is the Response Evaluation Criteria In Solid Tumors method, with ordinal outcomes defined as complete response, partial response, stable disease, and progressive disease. Traditional ordinal response modeling methods assume independence among the predictor variables and require that the number of samples (n) exceed the number of covariates (p). These are both violated in the context of high-throughput genomic studies. Recently, penalized models have been successfully applied to high-throughput genomic datasets in fitting linear, logistic, and Cox proportional hazards models with excellent performance. However, extension of penalized models to the ordinal response setting has not been fully described nor has software been made generally available. Herein we propose to apply the L1 penalization method to ordinal response models to enable modeling of common ordinal response data when a high-dimensional genomic data comprise the predictor space. This study will expand the scope of our current research by providing additional model-based ordinal classification methodologies applicable for high-dimensional datasets to accompany the heuristic based classification tree and random forest ordinal methodologies we have previously described. The specific aims of this application are to: (1) Develop R functions for implementing the stereotype logit model as well as an L1 penalized stereotype logit model for modeling an ordinal response. (2) Empirically examine the performance of the L1 penalized stereotype logit model and competitor ordinal response models by performing a simulation study and applying the models to publicly available microarray datasets. (3) Develop an R package for fitting a random-effects ordinal regression model for clustered ordinal response data. (4) Extend the random-effects ordinal regression model to include an L1 penalty term to accomodate high-dimensional covariate spaces and empirically examine the performance of the L1random-effects ordinal regression model through application to microarray data. Studies involving protocol biopsies where both histopathological assessment and microarray studies are performed at the same time point are increasingly being performed, so that the methodology and software developed in this application will provide unique informatic methods for analyzing such data. Moreover, the ordinal response extensions proposed in this application, though initially conceived of by considering microarray applications, will be broadly applicable to a variety of health, social, and behavioral research fields, which commonly collect human preference data and other responses on an ordinal scale.

Public health relevance
Most histopathological variables are reported on an ordinal scale. Studies involving protocol biopsies where both histopathological assessment and microarray studies are performed at the same time point are increasingly being performed, and the software developed in this application will provide unique informatic tools for analyzing such data. Moreover, the informatic methods proposed in this application, though initially conceived of by con- sidering microarray applications, will be broadly applicable to a variety of health, social, and behavioral research fields, which commonly collect human preference data and other responses on an ordinal scale.